Emotional Cognition: Establishing Constructs and Neural-Behavioral Mechanisms in Older Adults with Depression (ENSURE)

PROJECT ABSTRACT
Major depressive disorder (MDD) in adults across the lifespan is a leading cause of disability worldwide.
Cognitive dysfunction is highly prevalent in MDD and is associated with functional impairments and reduced
quality of life. Cognitive dysfunction has been noted across non-emotional, “cold” cognitive functions, such as
executive function, memory, and attention, as well as emotionally-laden, “hot” cognitive functions, such as
emotion processing, negative attentional biases, reward processing, and social cognition. Despite ample
evidence of impairments associated with hot cognitive function, behaviors, and associated neural circuity,
limited information exists regarding hot cognitive function in adults across the lifespan with MDD. Given the
importance of cognitive dysfunction on disease course and overall functioning in MDD, it is critical to identify
mechanisms of action and targeted treatment approaches that will improve associated cognitive dysfunction
and achieve the ultimate goal of improving overall disease course, functioning, and quality of life. Identification
of regional brain network alterations associated with particular hot and cold cognitive functions and treatments
that modify these regions will move us closer toward mechanism-based personalized medicine and improved
patient outcomes. A first critical step in this long-term endeavor and goal of this R21 study is to better
characterize hot cognitive dysfunction in MDD, inform potential effects of age on these dysfunctions,
and elucidate associated underlying neurocircuitry in older adults. In the proposed pilot study, we further
our prior work in adults across the lifespan with MDD and cold cognitive impairment by examining the
understudied area of hot cognitive function. This clinically significant and innovative 2-year preliminary project
has two aims: 1) Establish and integrate hot and cold cognitive dysfunction in adults across the lifespan, and 2)
Establish and compare specific brain networks underlying hot and cold cognitive tasks. The proposed study
engages an interdisciplinary team with diverse expertise including clinical neuropsychology,
cognitive/behavioral neuroscience, neuroimaging, and biostatistics. Through the synthesis of clinical metrics,
hot and cold cognitive metrics, and resting-state magnetoencephalography (MEG), we will characterize hot
cognitive dysfunction in MDD, examine potential effects of age, and inform associated underlying
neurocircuitry. The new knowledge gained in this pilot study will allow us to develop a program of research that
will then use non-invasive neuromodulation technology (e.g., transcranial magnetic stimulation) to perturb
neurocircuitry and confirm the mechanisms underlying both hot and cold cognitive function. Following
mechanistic confirmation, subsequent investigations will develop mechanism-based targeted treatment(s) to
improve cognitive impairments. These investigations have strong clinical significance and innovation for adults
across the lifespan with MDD as they will lead to new and mechanism-based personalized therapeutics,
remediate cognitive dysfunction, and optimize overall health.

Public health relevance
PUBLIC HEALTH RELEVANCE Major depressive disorder is the second leading cause of global disability and results in significant functional impairment, morbidity, and mortality. Despite evidence of impairments associated with emotionally-laden (i.e., hot) cognitive processes and behaviors, there remains significantly limited information regarding hot cognitive function in adults across the lifespan with depression that hinders mechanistic understanding and new treatment development. The knowledge gained in this preliminary pilot study will provide the necessary information to create a program of research to inform underlying mechanisms of hot cognitive function and confirm such mechanisms of action to then develop new and personalized mechanism-based therapeutics to remediate hot cognitive dysfunction and optimize overall health outcomes.